Spatially resolved multiomics profiling of microbes and their host tissue

PROJECT SUMMARY/ABSTRACT
Microbial cell populations can be highly heterogeneous, which is crucial for strain survival in complex
conditions such as antibiotic treatment. Apparently, the cell-to-cell heterogeneity cannot be revealed using
traditional bulk sequencing techniques. Single-cell based approaches for microbial cells are emerging to tackle
this question, however, the spatial context information, crucial for understanding the microbe-host interactions,
is not collected. As of current, we still lack high resolution spatial omics tools to study microbes and their
residing mammalian host. Most currently available NGS based spatial transcriptome platforms are not
compatible with bacteria profiling due to three reasons: 1) Bacteria cell walls are highly diverse in thickness
and composition, which prevents the reagents such as reverse transcriptase and primers to enter the cell,
especially for Gram Positive ones with thick cell walls; 2) mRNAs of bacteria cells are sparse and have short
half-life; 3) bacteria mRNA lacks poly-A tail in RNA sequence. During the past 5 years, I developed DBiT-seq
(Deterministic barcoding in tissue), the first high resolution spatial proteo-transcriptome platform, which have
been widely applied to neuroscience, development, and cancer studies in human. I further reported the
Spatial-CITE-seq technique which can co-mapping ~300 surface proteins and the whole transcriptome of
various tissue types. I propose in the next five years the development of a new spatial sequencing technology
called microDBiT, which will be the first spatial proteo-transcriptome platform that can map microbes and the
host cells within the spatial context. At the initial stage, we will design and use the slides of cultured Gram
positive bacteria S.aureus and negative bacteria E. coli as a model to optimize the key steps of microDBiT
protocol, including cell wall digestion, mRNA polyadenylation, reverse transcription and in cell ligation. We will
next develop the microDBiT protocol for microbe and host cell co-mapping using gut tissues obtained from
bacteria colonized germ-free C57BL/6 mice. Lastly, we will apply the microDBiT to map out the gene
expression profile of pathogens and the patient cells in inflammatory bowel disease (IBD). Since metabolites
of microbes are considered important pathways that influence the host cell behavior, we will meanwhile include
an antibody panel of host receptors and study how the metabolites will influence the gene expression of host
cells. This technique will ultimately enable high-throughput and high-resolution characterization of spatial
heterogeneity of microbes and their interaction with the host cells. In the long run, we will build microDBiT into
a comprehensive platform that could be applied to diverse microbe and host systems at different omics levels
(Genomics, Transcriptomics, Epigenomics, etc.).

Public health relevance
PROJECT NARRATIVE Microbes such as Bacteria influence the healthiness of their host in many different ways. To understand how the microbes interact with their host, we need tools to characterize the microbes spatial distribution and also their cellular status. This project aims to build a widely applicable spatial RNA and protein sequencing platform to understand microbe status, spatial organization and their interactions with their host.